Control of multilineage hematopoiesis by 5' cap-proximal modification

PROJECT SUMMARY/ABSTRACT
This proposal outlines a five-year plan to prepare the PI, Dr. Andrew Levine, for an academic career as a
physician-scientist. Dr. Levine received his MD/PhD degrees from the Weill Cornell/Rockefeller/Sloan Kettering
Tri-Institutional MD-PhD program and completed residency and fellowship training in Laboratory Medicine and
Hematopathology at the University of California, San Francisco (UCSF), where he is currently a Clinical
Instructor. Dr. Levine has developed a mentored research plan together with Dr. Davide Ruggero, a Professor of
Urology at UCSF and an expert in the field of post-transcriptional RNA regulatory mechanisms at the organismal
level. Dr. Ruggero has served as a mentor to numerous trainees, many of whom have obtained independent
positions as faculty in academia or are running their own research groups in industry. The mentorship plan
ensures Dr. Levine’s full access to the resources and expertise of UCSF, a world-class research institution, which
will provide an outstanding environment for Dr. Levine to progress to scientific and career independence. Dr.
Levine has also assembled a K08 advisory committee composed of mostly senior investigators and physician-
scientists whose scientific expertise and mentorship will greatly assist Dr. Levine’s career development. They
include Drs. Kevin Shannon, Samie Jaffrey, and Hani Goodarzi. In addition, Dr. Levine will participate in formal
coursework, retreats, seminars, and workshops including through the UCSF Graduate Program, UCSF Office of
Career Development, UCSF Clinical and Translational Sciences Institute, and UC Davis Genome Center. Finally,
through the Ruggero laboratory and UCSF core facilities, Dr. Levine will have direct access to an extraordinary
combination of scientific resources. Dr. Levine’s research proposal seeks to understand the role of post-
transcriptional RNA regulatory mechanisms in hematopoiesis. Specifically, mRNA nucleotide modification is
increasingly appreciated to constitute one major yet poorly understood RNA regulatory mechanism that is
commonly affected in bone marrow failure syndromes and hematopoietic neoplasms. During Dr. Levine’s time
as a mentee of Dr. Ruggero, he has discovered that RNA cap-proximal nucleotide methylation, mediated by Cap
methyltransferase 2 (CMTR2), plays a critical role in balancing multilineage hematopoiesis. In Aim 1, through
use of novel genetic models Dr. Levine will elucidate the precise developmental stage(s) at which CMTR2 is
required for hematopoiesis. In Aim 2, through use of cell culture and in vivo models and cutting-edge sequencing
technologies, Dr. Levine will explore the hypothesis that CMTR2 mediates its effects by regulating the translation
and stability of key subsets of mRNAs within hematopoietic stem/progenitor cells to influence cell fate choices.
These experiments will elucidate the in vivo workings of a poorly understood epitranscriptomic mark, and will
elucidate how the presence of a single base modification on RNAs enforces complex cellular differentiation
pathways during hematopoietic development. These studies will moreover provide an ideal platform for Dr.
Levine to complete his training and launch his independent career.

Public health relevance
PROJECT NARRATIVE The modification of RNA nucleotides by dedicated enzymes is increasingly appreciated to constitute a major yet poorly understood RNA regulatory mechanism with essential functions in hematopoiesis. Alterations in RNA modifications are associated with multiple hematopoietic defects including hematopoietic neoplasms (e.g., myelodysplastic syndrome), interferonopathies (e.g., Aicardi-Goutières syndrome), and bone marrow failure syndromes (e.g., Dyskeratosis Congenita). This project seeks to elucidate the cellular and molecular mechanisms by which a single RNA nucleotide modification, generated by Cap methyltransferase 2 (CMTR2), enforces complex cellular differentiation pathways in hematopoietic stem and progenitor cells.